MAXILLARY EXPANSION USING LASER SPECKLEGRAMMETRY

The knowledge of biomechanics of skeletal reactions incident to maxillary expansion procedures will allow the clinician to obtain more effective and predictable treatment results, if he can determine the centers of rotation that are produced. Previous studies have been limited in accuracy and in describing three-dimensional displacements. In this proposal, the recently developed procedures of laser speckle metrology will be used for accurate determination of three-dimensional motions of facial bones under known loading. Data produce will include: 1) displacements of the maxilla and zygoma in respect to the frontal bone, 2) description of displacement geometries of the interface between the facial bones and 3) comparison of the horizontal increase in width of the dental arch, with the horizontal width increase of different vertical levels of the maxilla. Ten human skull specimens will be loaded by known force system applied through an estimated center of resistance of the tooth segment, by means of dead weight. Forces, ranging in magnitude from 200 grams per side of the specimen, to 1,600 grams per side of the specimen, will be applied in 200 gram increments. For each force system, a double exposure specklegram will be recorded, processed and interpreted for quantitative information of motions of skull bones. The laser speckle technique does not require any special preparation of the models, and provides non-invasive, precise measurement of displacements/deformations as large as 1.5 mm, with an accuracy of 0.2 Mum.